Evaluation of growth potential of ice-free vitrified heart valves in a pediatric porcine model.

Abstract: This diversity administrative supplement proposal is focused on obtaining postdoctoral support for
an outstanding individual, Dr. Kamala Sundararaj, to work on our Phase I STTR grant directed at translation of
ice-free cryopreservation of heart valves for pediatrics and be trained in small business entrepreneurship.
Heart valve replacement in children is a serious problem because there are no heart valve implants that grow
with the patient. The valves that are currently employed need to be changed as the patient grows with a very
high associated mortality rate (~40%). In response to this clinical need, we are pioneering an entirely new
approach to deliver growing heart valve implants, which we are calling partial heart transplantation (PHT). PHT
differs from heart transplantation because only the part of the heart containing a valve is transplanted. Based
on our preliminary data in immunosuppressed piglets, we recently performed the world’s first human partial
heart transplant on 4/22/2022 with demonstrated valve growth. However, the chance of a donor partial heart
transplant being available at just the right time is low. Therefore, we propose development of a network of
tissue banks with technology licenses at major pediatric cardiovascular medical centers nationwide in
preparation for clinical application. Our central hypothesis is that vitrified and nanowarmed PHTs can fulfill both
their hemodynamic and biological functions after orthotopic transplantation in growing children. In this Phase I
proposal there are three specific aims: First we propose optimization of short-term preservation protocols. Our
working hypothesis for this aim is that PHTs will tolerate longer post-mortem cold ischemic times than intact
hearts. The impact of procurement and refrigeration on piglet-derived PHTs will be evaluated by assessment
of viability in vitro. This will establish the anticipated geographic range for PHT procurement after dissection
based upon estimated refrigerated travel time. In the second specific aim we will optimize vitrification protocols
for PHTs. Our working hypothesis for this aim is that ice-free cryo-preservation employing tissue vitrification,
rapid nanowarming and apoptosis inhibition developed for adult porcine pulmonary heart valves can be further
optimized for smaller PHTs required for pediatric cases. Different cryoprotectant loading times, exposure
conditions, and apoptosis inhibitors will be evaluated by assessment of viability in vitro. This will establish the
optimal vitrification protocol for pediatric PHTs. In the final aim we will evaluate post-transplant growth, leaflet
viability and hemodynamic function of optimally vitrified and nanowarmed cryopreserved PHTs. Our working
hypothesis for this aim is that optimized protocols will allow vitrified PHTs that were banked for one month to
function in vivo like fresh PHTs. The optimized protocols developed in the earlier aims will be evaluated in a
swine leukocyte antigen matched growing immunosuppressed piglet PHT model by transplantation. This will
establish the PHT vitrification, warming, and banking methods for future clinical application. At the conclusion
of these aims it is anticipated that Dr. Sundaraj will have the necessary tools to establish herself as a
successful independent investigator and become an entrepreneur.

Public health relevance
Narrative: Our Phase I SBIR project is a great opportunity for Dr. Sundararaj to learn about small business opportunities because there are huge markets for research, diagnostic and clinical applications of our technology. Strategic assessment of the field has identified the need for better preservation methods because freezing methods of cryopreservation have been shown to damage tissues and organs due to ice formation. Congenital heart defects cause over 180,000 neonatal and infant deaths per year world-wide. Many of these deaths are caused by heart valve dysfunction and the poor treatment options available. We propose development of living partial heart transplants that can be banked after ice-free vitrification and nanowarmed rapidly from cryogenic storage temperatures to avoid risks of ice-induced tissue damage. Commercialization will be by development of a network of tissue banks with HLA and blood group antigen typed tissues available for matching with patients upon demand.